The Molecular Vector Physiology Laboratory at New Mexico State University

This ‘Research Supplement to Promote Diversity in Health-Related Research’ will
support April Lopez in the next 2.5 years while she’s earning a doctoral degree in
Biology. Ms. Lopez will conduct research in the Molecular Vector Physiology Laboratory at
New Mexico State University on the olfactory physiology of blood-sucking arthropod disease
vectors. At the end of her training, she will be an extremely competitive candidate for positions
in academia and industry.

Public health relevance
This ‘Research Supplement to Promote Diversity in Health-Related Research’ will support April Lopez in the next 2.5 years while she’s earning a doctoral degree in Biology.